Restoring Proprioception to Improve Balance and Gait in Lower-Limb Amputees - COVID-19 Supplement

No change from original proposal submission.

Public health relevance
No change from original proposal submission.